Michigan State University VDL Vet-LIRN 2021

PAR-18-604 Vet-LIRN Network Capacity-Building Project Michigan State University Project Summary The Toxicology Section of the Michigan State University Veterinary Diagnostic Laboratory works in coordination with the FDA Vet-LIRN and the Food Emergency Response Network (FERN) to monitor, test, and report on chemical food contaminants in an effort to provide effective communication of laboratory findings to protect the nation’s food/feed supply. Testing of food products for chemical residues, including antimicrobial drugs and the naturally occurring fungal contaminant mycotoxins, are routinely performed by liquid chromatography tandem mass spectrometry. Newer methods for the detection of multiple drug residues in food products (Becker et al, 2004; Aguilera-Luiz et al, 2008; Heller et al, 2006, Tang et al, 2012) have been described for ultra-high performance liquid chromatography tandem mass spectrometers. The recent acquisition of a UPLC-MS/MS has greatly enhanced our capabilities and provides surge capacity with high throughput for Vet-LIRN and FERN- directed product testing. However, the current system LC-MS/MS system makes use of nitrogen cylinders instead of a continuous source of high purity gas. Additionally, sample preparation time is currently limited by the ability to remove solvent by gas evaporation. The acquisition of a nitrogen generator and a nitrogen evaporation unit will allow for increased sample capacity and throughput without interruption in analytical testing.

Public health relevance
PAR-18-604 Vet-LIRN Network Capacity-Building Project Michigan State University Project Narrative The MSU VDL will acquire a nitrogen generator to support continuous gas input to the previously acquired AB Sciex 6500 QTrap. This instrument has the capability of handling high-throughput veterinary drug residue and chemical contaminant detection in support of coordinated testing directed by FDA Vet-LIRN and FERN. Additionally, a nitrogen evaporator will be acquired to increase sample processing capacity and throughput.